ShEEP Request for High Resolution Desktop MicroCT System

Requested Equipment: This request is for a Bruker Skyscan 1272 CMOS Edition high-resolution desktop
microcomputed tomography (microCT) system, a 16-sample automatic tube changer with custom 3D printed
sample tubes, a calcium-hydroxy apatite bone mineral density (BMD) phantom set, and a computer
workstation with Bruker software necessary to operate the system and visualize / analyze 3D datasets.
Equipment Justification: The North Florida / South Georgia Veterans Health System (NF/SGVHS) is the
largest VA healthcare system in the US and has a robust research program with diverse imaging needs. To
address this, NF/SGVHS established the Preclinical Musculoskeletal Imaging Core (PMIC) Lab, a centralized
preclinical imaging core facility. For more than a decade, the PMIC Lab has provided access to and training on
microCT systems, along with fee basis imaging, to scientists at NF/SGVHS and at other VA and academic
centers. The Skyscan 1172 (old model) microCT is the most utilized PMIC Lab Core Equipment. However, this
system is >10-years old and at its expected end-of-life. To facilitate our ongoing imaging needs, we request a
Skyscan 1272 (new model) high-resolution microCT. The Skyscan 1272 is the highest resolution microCT on
the market and images fine details as small as 0.45 µm (submicron resolution), using phase-contrast
enhancement, which will improve our ability to image small anatomical structures (e.g., microvasculature, bone
lacunae, and nerve fascicles). The 16-sample tube changer is an accessory that is exclusive to the Skyscan
1272, which automatically changes sample tubes upon completion of a scan and initiates each new scan via
user programmed software. In doing so, the tube changer increases device availability by allowing continuous
24-hr/day microCT scanning without direct user supervision. This will permit us to grow our user base by
simultaneously increasing device availability and by reducing microCT costs, due to less technician time. In
doing so, we will be able to recruit Users who may not be able to typically afford high-resolution imaging (e.g.,
those collecting preliminary data for proposals), which will increase our likelihood of success on future VA and
non-VA grants that are increasingly dependent upon the use of high-resolution imaging.
Projected Use: We have 4 Major VA Users, 5 Minor VA Users, and 8 Academic Users (17 total users) who
have ongoing or expected microCT needs. Major Users have VA Merit, Career Development, Cooperative
Study, and/or Small Projects in Rehabilitation Research awards. Minor Users have funding via the same VA
mechanisms and/or from NIH, DOD, or private foundations. Academic Users have tertiary microCT priority,
which is facilitated via fee basis imaging, assuming the research does not interfere with Major / Minor Users
and is relevant to Veterans’ health. We anticipate 40+ hours/week of microCT use throughout the lifespan of
this equipment, based on past microCT use and future projections. VA Users will exceed 75% of machine time,
with Major VA Users constituting >50% of use time.
Projects Supported and Benefit to Veterans: The PMIC Lab has established numerous microCT protocols
to assess the 3D microstructure of bone, vasculature, and other soft tissues. The Users on this proposal
assess changes in these tissues in small animal models of spinal cord injury, osteoporosis, osteoarthritis,
obesity, cancer, and other conditions that impact Veterans’ health. The requested Skyscan 1272 microCT
system will allow the PMIC Lab to support the imaging needs of these investigators, which will ultimately
benefit the health of Veterans, and will permit us to expand our microCT expertise to include the assessment of
bone lacunae, microvasculature, and nerve fascicles that are best visualized at submicron resolutions.

Public health relevance
Many scientists at our VA station are evaluating bone, vascular, and soft tissue responses to neurotrauma, obesity, osteoporosis, cancer, and other chronic health conditions that are prevalent in Veterans. Much of this work requires high-resolution 3D imaging of the microstructure of excised bone and vasculature, which has been facilitated for >10-years by a desktop microCT system in our centralized preclinical imaging core facility. This grant seeks to acquire a Bruker Skyscan 1272 (new model) high-resolution microCT system to replace our current desktop microCT system, which has reached its expected end-of-life, along with accessories that will improve our imaging capabilities, increase device availability, and reduce long-term operational costs. Access to this device will ensure continuity in high-resolution 3D imaging services available at our facility, which is needed for ongoing and future studies that are focused on improving Veterans’ health.